Core B: Biostatistics and Bioinformatics

CORE B: SUMMARY/ABSTRACT
The Biostatistics and Bioinformatics Core’s primary goal is to collaborate with the P01 Investigators and other
Core resource scientists to ensure that research conducted within the framework of this P01 program adheres
to the highest standards of quality, rigor, and reproducibility. The overarching goal of this P01 is to develop a
precision medicine platform that enhances the personalization of breast cancer screening and prevention. This
will be achieved through the application of subtype-specific risk assessment, risk-based screening, and risk
reduction strategies. This ambitious initiative involves: Expanding the enrollment of the WISDOM 1.0 study to
an extended network and evaluating the performance of our subtype-specific risk predictors (WISDOM 2.0) in
Project 1; Updating risk models by incorporating polygenic risk scores (PRS’), mammographic AI, and clinical
factors to predict specific subtypes of breast cancers (fast vs. slow-growing) in Projects 2 and 3; Utilizing the
MISCAN (CISNET) model to estimate the long-term benefits, potential harms, and cost-effectiveness of both
WISDOM 1.0 and 2.0. The BBC will serve as a centralized resource for comprehensive analytic,
computational, and data management support to ensure the success of individual projects and the P01 as a
whole. It is committed to provide timely support tailored to the specific needs of each project and Core, using
best practices and innovations in biostatistics/ bioinformatics/ machine learning/ data science. Administrative
efficiency will be achieved through centralized task prioritization and milestone tracking. Cost effectiveness will
be achieved by leveraging existing expertise and infrastructure. Under Aim 2 (Providing Centralized Data
Management) in accordance with NIH’s data sharing and privacy requirements and reproducible research
principles, we will extend I-SPY 2’s cloud-based platform and incorporate WISDOM 1.0 data collection
infrastructure to establish a secure, integrated cloud-based platform for this P01. Comprehensive support will
be provided across all phases of research endeavors, encompassing everything from shaping research
inquiries to gathering, analyzing, interpreting data, and disseminating results. The specific nature of
collaboration will be fine-tuned to the unique scientific context and the distinct biostatistics, bioinformatics and
data management needs of each project. Throughout the development of P01, Core personnel have engaged
with project investigators individually, providing consultation on study design and analysis for proposed studies
in each program application.

Public health relevance
CORE B: PROJECT NARRATIVE The primary goal of Core B (Biostatistics and Bioinformatics) is to collaborate with the P01 Investigators and other Core resource scientists to ensure that research conducted within this P01 program adheres to the highest standards of quality, rigor, and reproducibility. It will serve as a centralized resource for comprehensive analytic, computational, and data management support necessary for the success of individual projects and the P01 as a whole.